Alzheimer's Disease Research Center

Overall – Project Summary
The Alzheimer’s Disease Research Center (ADRC) was founded at Wake Forest School of Medicine (WFSM)
in 2016 to provide a comprehensive infrastructure for research on the pathophysiology, prevention, and
treatment of AD and related disorders (ADRD). The theme of our ADRC is to better understand early
transitions from normal aging to MCI and dementia, and to elucidate the role that metabolic and vascular
factors play in these transitions, through coordinated research activities spanning the translational spectrum.
No current therapies effectively prevent or treat the symptoms of AD. This chasm highlights the need to identify
antecedent biomarkers and risk factors that predict later-life vulnerability or resilience, in order to develop
strategies for prevention and early intervention. Metabolic and vascular disorders are powerful modifiable
factors that may contribute to the transitions from normal aging to MCI and ADRD. Such disorders are
epidemic in the Southeastern region surrounding the WF ADRC; more than 70% of adults over the age of 50
have prediabetes, diabetes, or hypertension. These disorders increase the risk of cognitive impairment and
dementia through complex interactions that are poorly understood. The WF ADRC seeks to provide resources
to better understand these interactions. We also seek to elucidate the multi-dimensional role that health
disparities play in influencing risk for AD. We emphasize engagement of African Americans and other
underrepresented groups, who are twice as likely to develop dementia, and have high rates of diabetes and
vascular disease. To promote innovative research on metabolic/vascular risk and health disparities, our
Outreach, Recruitment and Engagement and Clinical Cores have partnered to enroll and follow ~600
participants, carefully characterizing their vascular and glycemic status. Participants receive magnetic
resonance imaging and amyloid and tau positron emission tomography overseen by the Imaging Biomarker
Core. Valuable samples and data from this cohort are made widely available to the National Alzheimer’s
Coordinating Center, the National Centralized Repository for AD and other investigators by the Data
Management and Statistical Analysis and Neuropathology Cores, providing invaluable resources to address
numerous National Alzheimer’s Project Act milestones. The Neuropathology Core has also characterized novel
nonhuman primate models with methods that parallel the ADRC’s human cohort to promote translational
research. Finally, the ADRC and its Research Education Component provide training relating to AD, metabolic/
vascular factors and health disparities to a diverse cadre of new researchers, and education for patients and
families, health professionals, and the community. The prevalence of metabolic and vascular risk factors, their
role in onset, progression, and heterogeneity of ADRDs, and the strengths of the WF ADRC in these research
areas, ensure that we will make high-impact contributions to the search for strategies to treat and prevent AD.

Public health relevance
Overall – Project Narrative The Wake Forest Alzheimer’s Disease Research Center (ADRC) was founded only 4 years ago but has made remarkable progress toward its mission to promote research focused on strategies for preventing and treating Alzheimer’s disease (AD) and related disorders. We have a special focus on understanding how common medical conditions such as prediabetes, diabetes and hypertension influence the risk of AD, and how risk is influenced by health disparities of underrepresented groups. We will make important contributions that include critical research resources and highly trained investigators to the national ADRC network to address these questions and work together toward our common goal of developing effective methods to prevent, treat, and cure AD.